AGE RELATED CHANGES IN CAMP MEDIATED SYNAPTIC PLASTICITY

DESCRIPTION This application is based on the finding that beta receptor activation in conjunction with low frequency stimulation induces long term potentiation (called AC-LTP) in young rats but not in aged animals. The findings that aged rats have intact high frequency stimulation induced LTP and reduced short term responses to a beta agonist and forskolin suggest that a site after receptor activation is involved. The goal of this grant is to determine the biochemical defect, to determine if it is pre- or postsynaptic and to correlate changes in AC-LTP with spatial learning.